Vaccinology During and After COVID-19

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Vaccinology During and After COVID-19,
organized by Drs. Bali Pulendran, Robert Seder and Gagandeep Kang. The conference will be held in Atlanta,
Georgia from September 17-21, 2023.
Since its emergence, SARS-CoV-2 has radically transformed practically every dimension of our lives and
fueled an urgent global imperative to develop safe and effective vaccines. The stunning pace at which COVID-
19 vaccines have been developed is unprecedented in the history of vaccinology and has been catalyzed by
the rapid harnessing of innovative new technologies (e.g., mRNA vaccines) and major public and private
investments. The COVID-19 pandemic offered a unique vantage point from which to survey vaccinology as it
was for the past two centuries, since Edward Jenner and the eradication of smallpox, to how it is now, during
the time of COVID-19, and to consider what it could be in the post-COVID era. Equally important has been the
world’s focus on the economics, politics and ethics of how to ensure global equitable access to COVID-19
vaccines. This virus has certainly shone a spotlight on the field of vaccinology as it is, at the focal point of
immunology, microbiology, public health, clinical medicine, economics, sociology, ethics and international
diplomacy. Thus, some talks will also be focused on these broader issues surrounding the field. It is anticipated
that this conference will stimulate debate that helps enhance pandemic preparedness by redefining the way we
conceive of, make, test, license and distribute vaccines globally. Overall, this conference is designed to bring
together an interdisciplinary team of experts to discuss the lessons learnt from the COVID-19 pandemic, with a
particular focus on the immunology of vaccination.

Public health relevance
PROJECT NARRATIVE Vaccines have affected and saved more lives than virtually any other medical innovation in human history. And, as seen with the rapid development of the different types of COVID-19 vaccines, we can now use advances in technology and structural biology to develop novel therapeutics to combat infectious disease; however, the pandemic also highlighted the inequalities of access to these medications. Therefore, this Keystone Symposia conference represents a unique opportunity to bring together an interdisciplinary team of experts working in the field to discuss the future of vaccinology.